Priorities of Communities after Covid

In 2021, the 'Priorities of Communities after Covid' research team worked in collaboration with software developers at YETi CGI to design software that allows the use of the CHAT exercise through the online platform, Zoom. The research team has held meetings with its community partner, the DECIDERs Steering Committee, to decide what benefit programs should be offered for selection by participants in the CHAT exercise. Actuarial research has been completed to estimate the per/beneficiary and per capita costs of these benefit programs. Over the coming year, the content of this CHAT will be developed (the facilitator script, benefit descriptions, health event cards, pre- and post-exercise questionnaires), videos will be prepared for use in instructing study participants, recruitment of participants will take place, and CHAT sessions will be scheduled and held.